RFA-CK-22-008, TRANSMIT: Training Research Acumen in Students Modeling Infectious Threats

PROJECT SUMMARY/ABSTRACT
The ongoing COVID-19 pandemic has overwhelmed healthcare and public health systems,
underscoring the need to anticipate disease outbreaks and prepare resources such as hospital
beds and staff. One cost-effective and timely way to prepare resources to respond to these
outbreaks is through the use of mathematical modeling. Models can act as a virtual laboratory to
explore a variety of scenarios, interventions, or applications in a timely manner to inform policy
interventions. While the COVID-19 pandemic highlighted the gaps that models can fill, it also
highlighted a considerable gap in modeling: there is a lack of modeling professionals trained in
developing and applying transmission models to healthcare settings. In this proposal, we detail
three projects aimed to train three predoctoral fellows in different aspects of mathematical
modeling of healthcare associated pathogens. These projects tackle different pathogens and
components of disease transmission in a healthcare setting; and, while each project is distinct,
they dovetail nicely, resulting in a cohesive research program.
Project 1 tackles a critical component of disease transmission in healthcare settings: COVID-19
in long-term care facilities (LTCFs). Throughout the pandemic, LTCFs bore a disproportionate
burden of mortality. Yet, while it is clear that LTCFs important with regards to disease outcomes,
whether or not they exert selective forces on SARS-CoV-2 that have shaped global patterns of
pathogen evolution is not yet known. Here, we will develop models to quantify the phylogenetic
relationships between community and long-term care facility lineages to understand the viral
diversification attributable to healthcare settings. Project 2 explores the risk factors of patients
hospitalized with SARS-CoV-2 for acquiring multi-drug resistant organisms (MDROs). The rapid
spread of SARS-CoV-2 has changed to hospital infection control and antimicrobial stewardship
policies. One such change has been widespread potentially unnecessary antibiotic use among
hospitalized patients. Here, we will identify the characteristics of the sub-population
disproportionately impacted by co-infections with MDROs for patients hospitalized with SARS-
CoV-2. Project 3 integrates with both Project 1 and 2, to explore the evolution of antibiotic
resistance due to variable dose and off-target antibiotic use in healthcare settings. Patients in
hospitals and residents of LTCFs are exposed to a wide range of pathogens and treatments,
and many of these organisms have themselves been exposed to a wide range of environmental
antibiotics. Here, we will develop models of evolution to investigate the conditions that lead to
the most intractable infections.

Public health relevance
PROJECT NARATIVE The scale of the ongoing COVID-19 pandemic has magnified existing issues with healthcare and public health systems globally; highlighting the need to improve mathematical modeling capacity to respond to threats like COVID-19. This proposal aims to develop modeling capacity in three predoctoral fellows, training them in multiple modeling techniques to better understand transmission dynamics in long-term care facilities, MDRO acquisition risk in acute care settings, and the evolution of antibiotic resistance. Collectively, these projects will provide both improved workforce capacity and improved understanding of how SARS-CoV-2 and MDROs spread, evolve, and are acquired in healthcare facilities.